Improving linguistic health equity in prehospital emergency care

Project Summary
Language barriers in prehospital emergency care can deny patients live-saving clinical care and build distrust
with the emergency medical system. When non/limited English proficient (LEP) patients call 9-1-1, they are
more likely to experience delays, less likely to receive and perform pre-arrival instructions and more likely to
experience adverse health outcomes and unscheduled emergency department return visits than their English-
speaking counterparts. With 25 million LEP individuals in the United States we need a better understanding of
the gaps in prehospital emergency care and modify the system to promote health equity in care delivery.
In hospital and clinic settings, the gold standard for overcoming language barriers is the use of professional
interpreters, which has shown to improve care delivery, patient satisfaction and health outcomes. While over-
the-phone interpreter (OPI) use in the 9-1-1 Dispatch emergency setting can be critical to facilitating
assessment and pre-arrival instruction delivery, suboptimal utilization (over, under or delayed utilization of OPI)
can result in worsened outcomes. This may explain some of the disparities seen in research showing that 9-1-
1 calls with LEP callers more frequently result in triage errors, increased time to dispatching response, and that
pre-arrival instructions are often delayed and/or not performed by LEP callers.
We propose a multi-method study, guided by the Feldman-Stewart et al. (2005) provider-patient
communication framework, to increase our understanding of the complex interaction between LEP callers,
dispatchers and interpreters during the first critical minutes of emergency care. This study has three aims and
one sub-aim:
1) Identify call characteristics that are associated with use of OPI and associated communication and
care delivery outcomes during real-life 9-1-1 calls with LEP callers.
1a.) analyze three-way communication patterns between dispatcher, caller and OPI in a sample
of Spanish and Chinese (i.e., Mandarin/Cantonese) 9-1-1 calls with OPI.
2) Identify key dispatcher attributes associated with use of and time to OPI during simulated scenarios
(developed based on information collected in Aim#1), with LEP Spanish and Chinese mock callers.
3) Translate and disseminate the results of the study via training opportunities and policy
recommendations identified by emergency medical services (EMS) and community stakeholders, using
a participatory Delphi technique.
Our research group has contributed significantly to the existing research on linguistic inequities in prehospital
care. We bring our vast knowledge of the complexity of communication in an emergency setting and a 30-year
history of collaborative work with EMS and community partners to shed light on OPI use in prehospital care
and guide translation of findings into policies and training on OPI use in prehospital care delivery.

Public health relevance
Project Narrative Although use of interpreters is the “gold standard” in hospital and clinic settings for communicating with limited English proficient (LEP) patients, in prehospital emergency care interpreters are seldom used, and it is less clear when use of professional over-the-phone interpreter (OPI) services is appropriate or how 9-1-1 dispatchers decide on connecting to OPI during 9-1-1 calls with LEP callers. We propose a multi-method study to 1) Identify call characteristics that are associated with OPI use and associated communication and care delivery outcomes during real-life 9-1-1 calls with LEP callers and 2) Identify key dispatcher attributes associated with use of and time to OPI during simulated scenarios (developed based on information collected in Aim#1) with LEP Spanish, Mandarin and Cantonese mock callers. Third, we plan to translate and disseminate the results of the study via training opportunities and policy recommendations identified by emergency medical services (EMS) and community stakeholders, using a participatory Delphi technique.